Neuronal Physiology Core

Neuronal Physiology Core
Abstract:
The studies proposed in this Program Project will define the structure, function and regulation of
hindbrain neural circuitry that underlies gut-brain communication and ascertain alterations that
occur within this circuitry in response to bariatric surgery. To probe the function and regulation
of distinct neuronal populations within this circuitry, at the cellular level, the Neuronal Physiology
Core will conduct specialized assays of cellular function that are targeted to select neuronal
subtypes using genetically encoded tools combined with unique genetic mouse models. These
assays include 1. in vivo fiber photometry to measure calcium signals from genetically encoded
calcium indicator (GECI)-expressing hindbrain neuronal populations, as a readout of cellular
activity in response to stimuli, pre and post-VSG. 2. ex vivo electrophysiologial analysis of
genetically-labeled and indentified neurons to directly assess cellular mechanisms underlying
function and regulation pre and post vertical sleeve gastrectomy (VSG) 3.combined
optogenetics and ex vivo electrophysiology to assess the functional connectivity of defined
neuronal populations 4. in vivo optogenetic stimulation or inhibition of distinct genetically
targeted neuronal populations to assess the impact of their modulation on physiologic
processes (e.g. feeding behavior, conditioned place preference)

Public health relevance
Narrative The studies proposed in this Program Project will define the structure, function and regulation of hindbrain neural circuitry that underlies gut-brain communication. To probe the function and regulation of distinct neuronal populations within this circuitry the Neuronal Physiology Core will conduct specialized assays of cellular function using genetically encoded tools combined with unique genetic mouse models.